DEI supplement for Interplay between tau and PKA condensates in ADRD

Parent R21 Project Summary / Abstract
Provided on first page of Research Strategy as required per the FOA.

Public health relevance
Project Narrative The protein kinase PKA protects against dementia in Alzheimer’s disease and during aging, and drugs that activate PKA are in clinical development for the treatment of dementia. This proposal provides supplement support for D. Walter Saide, an individual from a Sexual and Gender Minority group, to investigate the ability of PKA to form liquid-like droplets in cells in order to gain a better understanding of PKA’s protective function in the brain.